In vivo hematopoietic stem cell gene therapy in a novel genetically humanized murine model of SCID-A

Project Summary/Abstract
A founder mutation in the ARTEMIS gene resulting in Severe Combined Immunodeficiency (SCID-A) is
common in the Athabascan-speaking Navajo and Apache populations (a minority group) in the United States.
One in 2,000 live births in this community have this devastating genetic disorder, resulting in a complete lack of
mature T and B lymphocytes. The current standard of care for these patients is a bone marrow transplant, which
often does not result in B cell reconstitution, carries risk of graft versus host disease, and necessitates harsh
preconditioning regimens. Clinical trials are ongoing for ex vivo gene therapy using a lentiviral vector to insert
additional copies of ARTEMIS in patient hematopoietic stem cells. We are pursuing a more targeted treatment
using Adenine Base Editor (ABE) to convert two bases of ARTEMIS without causing double-stranded breaks in
the genome. ABE can edit this mutation with a conservative amino acid substitution, replacing the premature
stop codon. The effect of this edit on hematopoietic stem cells' immune reconstitution ability has not yet been
examined. This proposed work aims to validate ABE conservative substitution as a viable therapy for SCID-A
and establish in vivo delivery methods to hematopoietic stem/progenitor cells (HSPCs) for immune reconstitution
using a novel, genetically humanized SCID-A mouse model that we recently developed.
Aim 1 will characterize the efficacy and safety of the conservative substitution strategy with multiple in vitro
Artemis assays in both a K562 SCID-A cell line and SCID-A murine hematopoietic stem cells. Aim 2 explores in
vivo delivery of therapeutic guide RNA and base editor mRNA to HSPCs in our SCID-A mouse model. Novel
cationic polymer micelles from the Reineke group will be tested in vivo along with recombinant adeno-associated
virus (rAAV) serotype 6 to establish the feasibility of immune reconstitution by edited HSPCs in vivo. This work
will lay the groundwork for potential in vivo base editor therapy clinical trials to treat SCID-A patients.
This project describes the work that Ella will perform throughout the remainder of graduate studies. During
the fellowship period, Ella will also undertake a career development plan to prepare for a future career as an
independent researcher at an academic institution. This includes support from numerous collaborators to
accomplish the research objectives, and training in new areas of biological research, such as polymer complex
delivery methods, rAAV production, and rigorous in vivo studies to assess the efficacy of SCID-A treatment using
ABE. These experiences, along with programming from the UMN’s Office of Graduate and Postdoctoral Studies
will provide Ella with the skills and knowledge necessary to achieve her career goals and desire to perform
impactful translational research.

Public health relevance
Public Health Relevance Severe Combined Immunodeficiency (SCID-A) is a form of severe combined immune deficiency caused by a mutation prevalent in Athabascan-language sharing indigenous populations; this mutation results in the lack of functional Artemis, a protein which is integral to the development of functional T and B cells. This proposal aims to establish adenine base editor (ABE) genetic correction of this mutation as a viable therapy for SCID-A and explore both viral and nonviral methods to deliver ABE to relevant cell types in vivo. The data generated from the proposed studies will further the clinical development of gene therapies for SCID-A and improve upon the current standard of care, hematopoietic stem cell transplantation, which is an incomplete cure accompanied by numerous side effects.